Roles for interstitial and airspace macrophages in resolution of pulmonary inflammation

Project Summary/Abstract
Inflammation is is a highly complex process that is a component of most forms of pulmonary disease. It
represents a response to tissue insult and normally (ideally) leads to return of tissue homeostasis, although,
depending on the initating stimulus, the repair process may also involve a transient fibrotic response (akin to
“wound heaing” in the skin). Macrophages are essential cells in these events, playing key roles in all steps in
the processes, orchestrating many elements of the repair/resolution and return to homeostasis; the
understaning of which is the primary focus of this proposal. Macropahges in the lung fall into two general
categories: 1) resident macrophages involved in maintaining the homeostasis and serving as sentinels to
detect the initial stimulus or injury and 2) recruited macrophages maturing from incoming monocytes. We and
others have recently identified unique macrophage subtypes (resident and recruited) within the pulmonary
interstitium in addition to those in the airspaces, but at this point, their specific responses to, or participation in,
the inflammatory responses and their resolution have not been determined. Accordingly, during this project we
will elucidate the roles for individual macrophage subsets in the resolution phase of the inflammatory response,
with the ultimate objective of devising therapeutic approaches for its enhancement. Using novel approaches to
target, lineage trace and manipulate the different macrophage populations we will determine their numbers,
functional programing state, and critically their specific location within the lungs over the course of inflammation
induced by four unrelated stimuli – two that lead to early resolution (bacterial lipopolysaccharide and H1N1
influenza infection) and two that include a transient fibrotic response during a more prolonged resolution
(bleomycin or HCl, the latter mimicking exposure to gastic contents). During inflammation, the resident
macrophages within the normal lung interstitium and airspaces increase in numbers but also are joined by
large numbers of recruited macrophages. In the processes of resolution, these excess macrophages are
removed and a major focus of the proposal will be determination of the modes of removal and the effects of
deliberately enhancing (or delaying) this removal on the desired return to homeostatic lung structure and
function. Key hypotheses to be explored include: 1) Unique macrophage properties during both iniation of
inflammation and especially its resolution, for subsets of interstitial macrophages (vs. those in the airspaces)
relating to their precise localization, for example within the bronchovascular bundles or in the subpleural
region). 2) Macrophages are recruited to inflamed lungs in waves, exhibiting unique programing properties,
with later recruited cells playing the key roles in inflammation resolution, including both the induction and
resolution of the transient fibrotic response. 3) The recruited macrophages themselves, in both the transient
and extended inflammatory circumstances are removed after undergoing extrinsic apoptosis.

Public health relevance
Project narrative Macrophages play key roles in maintening normal lung homeostasis, recognition of injury and infection in the majority of pulmonary diseases, intiation of lung inflammation and importantly for this project, contribution to resolution of the inflammation and return to the homeostatic state. Using a wide spectrum of experimental approaches we propose a comprehenisive analysis of macrophage numbers, functional properties and specific intra-pulmonary locations over the course of injury initiated by four unrelated stimuli that induce either rapidly resolving inflammatatory processes or those that include a significant, but transient, fibrosis. Particular emphasis will be placed on the more recently recognized, but highly understudied, roles played by unique macrophage subsets located within the pulmonary interstitium, with special emphasis on their behavior and contribution to restoration of homeostasis after the different inflammatory processes.